ETHANOL AND CD4 CELL DEPENDENT IMMUNITY

Ethanol consumption in humans and in experimental animals has been shown to depress many specific immune functions. It has been hypothesized that the depressed immune response may contribute to the increased prevalence of infectious diseases and tumors in alcoholics. Studies suggest that chronic ethanol consumption depresses T-lymphocyte helper function. CD4 T- helper cells can be divided into two distinct phenotypic subsets acting through different lymphokine secretion patterns. Th1 cells give rise to cell-mediated immunity; Th2 are responsible for antibody-mediated immunity. Parasitic infections in mice provide the premier examples of infections controlled exclusively by either the Thl or the Th2 system. Two of these models have been thoroughly investigated, (a) Leishmania major, a protozoan infection, where immunity is totally Thl dependent and (b)Strongyloides stercoralis, a nematode infection, where immunity is totally Th2 dependent. The effect of ethanol consumption on the development of protective immunity to these infections will be determined, thereby elucidating the effect of ethanol on Thl and Th2 function. The objectives of this study are to (i) to determine the appropriate protocol for the administration of ethanol to mice for the demonstration of an effect on CD4 cell function (ii) to determine the effect of ethanol on protective immune responses dependent on either Thl or Th2 cells and (iii) to investigate the mechanism by which ethanol causes an alteration in the protective immune response. The results obtained with these two parasitic infection models will provide information on the effects of ethanol consumption on protective immunity dependent on CD4 cells.